Molecular Center of Health and Disease

Overall-Abstract
Chronic diseases, such as heart disease, diabetes, and cancer are among the most prevalent health conditions
in the United States, responsible for 7 out of every 10 deaths. Mississippi ranks first or second in 8 of 10 leading
causes of death, with 90% of the population having 1-2 chronic diseases. While chronic diseases can be treated
through early intervention, targeted medical therapies, and improved diet and exercise, an understanding of
genetic susceptibility and molecular mechanisms involved in disease onset has the potential to halt progression
and return an individual to a healthier state. Advances in technology now allow for unprecedented insight into
genome complexity and its interaction with the environment using genomic, transcriptomic, proteomic, and
metabolomic datasets. The integration of these datasets with physiological information using computational
approaches can provide systematic insight into the molecular, cellular, and overall physiology associated with
the health-disease continuum. We propose to establish a new Phase I COBRE, the Molecular Center of Health
and Disease (MCHD) to facilitate research under a central theme of molecular physiology to enhance the depth
of education, mentorship, and training of researchers to generate unique opportunities in the application of omics
technology and computational biology. The MCHD will be comprised of multiple components including an
administrative unit, education and mentoring programs, a pilot project program, two research cores, and three
major project investigators. The overall objectives of the MCHD are: (1) to develop infrastructure and state-of-
the-art research core facilities essential for cutting edge basic, clinical, and translational approaches to study the
health and disease continuum. The MCHD, through Core B will enhance existing -omics technology (e.g., single
cell RNAseq and spatial transcriptomics), proteomic capabilities, and establish a new innovative core, involving
CRISPR/Cas9 gene-editing technology to interrogate gene function and biological pathways; and Core C will
establish critical computing infrastructure and computational biology analysis not currently available at the
University; (2) to establish meaningful education, mentoring programs, and research support for promising new
investigators to nurture them into productive, independently funded investigators, who will be effective
collaborators on multidisciplinary research teams. This will be accomplished through offering a “Genetic and -
Omics Academy” (didactic instruction and observership) to strengthen researcher understanding of molecular
and computational approaches, a robust mentoring program involving one-on-one and team mentoring, career
development opportunities, and providing a high level of research support through each core; and (3) to enhance
collaborations and interactions among investigators across multiple disciplines at UMMC, promote cooperation
between other IDeA supported programs, including existing COBRE, IDeA-CTR, and external partnership with
the Mississippi-INBRE.

Public health relevance
Overall-Narrative The health-disease continuum is a process through various states of health and disease (such as heart disease, diabetes, cancer, and Alzheimer’s) and can fluctuate throughout life. While chronic diseases can be treated, an understanding of genetic susceptibility and molecular mechanisms involved in disease onset has the potential to halt progression and return an individual to a healthy state. The proposed Molecular Center of Health and Disease, through a Phase I COBRE, seeks to apply innovative molecular technology and computational biology to enhance research, discovery, and innovation in understanding the health-disease continuum and lead to better interventions to improve health.